Establishing a link between habits and punishment resistance

01"#2&3)45#68!,9#-1-$!!*%&&'!!$(&.")'"!*###!!"#+&)#!"!#!!&/"!!!,"##,'*+'0,!"**
"!,&1#+!-"',!!"!,+!!,!"-+",",#!#!&-#,!!!!"!**0&1#"!!!"!*'#0#!&!!""-"!!!!"-!-#+****'
#!'0!#&,!!"!#"!!#-'!!-,-*!#!"!!'#&!#-!!*!!!-*!**
#!!!,!+!"!!-!"'-#!'&!'#+-##!,!!$##"&!!#,!#,#"!***

Public health relevance
PROJECTIVE NARRATIVE A hallmark feature of addiction is an uncontrollable urge to use drugs despite negative consequences. The proposed project will test the hypothesis that this behavior stems from a reduced ability to exert goal-directed control over drug-seeking habits. These studies will identify key neural networks underlying compulsive drug use in addiction.